A Mulit-Centered Prospective Study of Quality of Life in Adult Scoliosis

ABSTRACT The goal of this patient-oriented study is to obtain health-related quality of life (HRQOL) outcomes data on patients who present with adult symptomatic lumbar scoliosis (ASLS) pre- and post-treatment in order to facilitate the development of evidence-based treatment guidelines, improve patient care and optimize healthcare resource utilization. We are defining ASLS as Oswestry Disability Index (ODI) e20, Scoliosis Research Society (SRS) domain scores d4.0 and a Cobb measurement of e30° at baseline. This study will help us determine how much the current treatment, either nonoperative or operative, improves the lives of people with this pathology. Significance: The impetus for this critical effort is the significant burden of disease posed by adult scoliosis, which affects 2.5-4% of the North American population. The most symptomatic group of primary presentation ASLS patients are those between the ages of 40 and 80 with lumbar deformities - our target population for this study. This disease constitutes a significant problem in light of our aging population and the high cost of surgical treatment (at least $80,000 in hospital costs alone). Studies to date, however, have typically been limited, small, single institution and retrospective. The extent to which treatment benefits patients with ASLS is not well established. Preliminary data: The Spinal Deformity Study Group/Adult Deformity Outcomes section (SDSG/ADO), which was formed 7 years ago, has developed a multi-center effort specifically to study adult scoliosis and has established an infrastructure for collecting consistent multicenter data. The SDSG has 1) validated a disease-specific outcomes tool (the SRS patient-reported outcomes instrument) for adult spinal deformity; 2) developed and validated disease-specific radiographic tools; 3) analyzed outcomes for certain interventions for comparison of treatments; and 4) collected preliminary data regarding the impact of treatments on patient outcomes. Methods: The study will comprise a multicenter, prospective, randomized controlled trial (RCT) (30%) and consecutive cohort study (70%) of patients receiving current standard-of-care treatments and will use uniform clinical and radiographic assessments that have been validated by our group for assessment of these patients. Both nonoperative and operative care will be stan- dardized within the 5 centers. Quality of life will be assessed by SRS-QOL, ODI, SF-12, numerical rating scale (NRS) back pain and leg pain scores. Functional measures will include a walking treadmill test to assess speed and endurance in patients at baseline and 2 years post-treatment. Primary Aims: Measure the impacts and compare the outcomes of nonoperative and operative treatments in ASLS patients. Innovation: No outcomes study exists in any current peer-reviewed literature to document the effect of both nonoperative and operative treatment on any aspect of primary presentation adult spinal deformity.

Public health relevance
PROJECT NARRATIVE The impetus for this critical effort is the significant burden of disease posed by adult symptomatic lumbar scoliosis (ASLS). This disease constitutes a growing problem in light of our aging population and the high cost of surgical treatment (at least $80,000 in hospital costs alone). Our study will facilitate the development of evidence-based treatment guidelines, improve patient care, and optimize healthcare resource utilization. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS AND HYPOTHESES Adult scoliosis, which encompasses patients with curvature of the spine of varying magnitudes caused or exacerbated by degenerative disc and joint disease, is a common disorder that significantly impacts quality of life. Both the prevalence and severity of lumbar curves increase steadily in older adults and an estimated 5.3 million Americans suffer from adult scoliosis. Decision making in adult scoliosis is complex, especially in the older population and in patients with significant comorbidities, making management options challenging and resource intensive. The hospitalization cost for surgical treatment of adult scoliosis in 2003 was estimated to be ~$235.5 million;4 at the same time, the nonoperative care of adult scoliosis is also resource intensive, with symptomatic patients incurring significant healthcare costs from pain medications, physical therapy, injections, and time away from work.5 The nonoperative and operative management of adult scoliosis lacks guidance from an evidence-based approach. The major purpose of this study is to evaluate the effectiveness of surgical and nonoperative treatments of patients with adult symptomatic lumbar scoliosis (ASLS). We propose to carry out a multicenter prospective randomized study with a concurrent prospective observational cohort to evaluate the effectiveness of nonoperative and operative interventions, and to identify important clinical and radiographic determinants of outcome in the management of ASLS. " Specific Aim #1: Compare the outcomes of surgery and nonoperative treatment in patients aged 40 to 80 with ASLS defined as a lumbar curve with a coronal Cobb measurement of 30° or more, and either of the following: Oswestry Disability Index (ODI) score of 20 or more; or Scoliosis Research Society Quality of Life (SRS-QOL) instrument score of 4.0 or less, in the domains of pain, function and/or appearance. Null Hypothesis: Nonoperative and operative treatment groups will have similar outcomes at follow-up. Significance: The substantial expense of both nonoperative and operative treatment is compounded by the quality of life lost when an inferior treatment is selected. Innovation: No such comparative treatment study of primary presentation adult spinal deformity and/or ASLS exists in peer-reviewed orthopaedic or neurosurgical literature. " Specific Aim #2: Evaluate the impact of patient factors (age, gender, socioeconomic status, education) and comorbidities [mental health, body mass index (BMI) and bone mineral density (BMD)] on adverse events and treatment outcomes for both the nonoperative and operative arms. Incorporate these variables into a prediction model to help identify those patients most likely to benefit from either a surgical or nonoperative approach. Hypothesis: Age, gender, socioeconomic status, education, and comorbidities will have an impact on the final result at 2-4 years post-intervention. Significance: A valid predictive model would help to target interventions to those patients most likely to benefit from one form of treatment over the other and to better inform patients about their particular risks and likely outcomes in order to better incorporate their values and preferences into an informed treatment choice. The investigators in this study are members of the Spinal Deformity Study Group (SDSG), a multicenter research group formed seven years ago representing the leading academic researchers of scoliosis in North America. Uniform clinical and radiographic assessments that have been validated by our group for assessment of these patients will be used. Both nonoperative and operative care will be standardized within the five centers. Only adult symptomatic lumbar scoliosis (ASLS) patients who have not had previous spinal deformity surgery will be analyzed in order to provide a relatively homogenous cohort. This study will apply an evidence-based approach to adult spinal deformity, and we anticipate that it will provide new data about best clinical practices for management of ASLS. To date our group of investigators has gathered a substantial amount of preliminary data that supports the research being proposed. In addition, we are partnering with experienced clinical trialists with a proven track record of performing high-quality randomized trials in orthopaedic surgery including the Spine Patient Outcomes Research Trial (SPORT). Intent-to-treat analysis of randomized trials will provide the most internally valid, least confounded estimate of the effect of surgery, while inclusion of the prospective observational cohort will help assess the external validity of the results and include a much broader spectrum of patients with ASLS than an RCT alone.